CLOPIDOGREL DOSING IN HUMAN ARTERIAL THROMBUS FORMATION

The specific aims of this protocols are to test (a) whether clopidogrel plus aspirin prevents more thrombus formation than aspirin alone and, (b) measure the antithrombotic response of clopidogrel at 2 hours after an oral dose of 300 mg (load) vs 75 mg (no-load) in comparison with one week of treatment in patients with chronic coronary or peripheral arterial disease and on chronic aspirin 325 mg per day.